Whole genome sequencing laboratory, procurement of supplies and reagents and equipment maintenance for surveillance, outbreak assessment, and data mining.

Summary:
Louisiana Animal Disease Diagnostic Laboratory (LADDL) is one of four whole genome
sequencing laboratories selected by Vet-LIRN to participate in a pilot project using
Whole Genome Sequencing (WGS) to monitor antimicrobial resistance in zoonotic
pathogens. Long term goals of this proposal are to add genomic data from animal or
animal feed bacterial isolates to National Antimicrobial Resistance Monitoring System
and to develop a rapid response network for accurate resolution of putative animal food-
borne disease outbreaks. This project has 3 specific aims: 1. Provide funding for
supplies, reagents and equipment maintenance for continuation of Vet-LIRN’s pilot
Antimicrobial Resistance (AMR) and Sequencing Project. 2. Through whole genome
sequencing: a) provide surveillance of antimicrobial resistance in animal feeds and in
infected animals; b) build reference databases to aid in solving foodborne outbreaks
more efficiently; and c) aid foodborne disease investigations by linking food sources and
clusters of disease. 3. Provide support and testing for diagnostic cases or pathogens of
interest referred by CVM-Vet-LIRN.
Antimicrobial resistance is a constant and growing threat to both human and animal
health. Whole genome sequencing is one of the recent and more powerful tools to
study it and monitor its development and progression. Sequencing also has shown
excellent utility in the epidemiological investigations of food-borne disease outbreaks.

Public health relevance
Project narrative: The work performed under this project will allow continued investigation into human and animal food safety by providing new technologies such as Whole Genome Sequencing (WGS). WGS provides real time data that aids in solving foodborne outbreaks faster by linking food sources to clusters of illness. Continued investment in new technologies is crucial to support an expanding testing volume while sustaining rapid detection and public health response.